Mass Spectrometry Shared Resource

MASS SPECTROMETRY SHARED RESOURCE – PROJECT SUMMARY/ABSTRACT
The Mass Spectrometry Shared Resource is a specialized facility with the primary goal of providing CSHL
Cancer Center members with support for proteomic and metabolomic studies. The Mass Spectrometry Shared
Resource is housed within the Keck Structural Biology lab on the ground floor of the Beckman building. Led by
Faculty Head Darryl Pappin Ph.D., the Mass Spectrometry Shared Resource provides Cancer Center members
with access to up-to-date mass spectrometry instrumentation and specialized technical expertise. Services used
by the majority of Cancer Center members include protein and protein complex identification, characterization of
protein post-translational modifications, quantitative targeted MRM and PRM assays, and quantitative whole-
proteome screens using 2D LCMS with iTRAQ/TMT, SILAC or label-free methods. For Metabolomics, the Mass
Spectrometry Shared Resource provides targeted and untargeted analyses for a diverse range of compound
classes. More specialized services have undertaken quantitative phosphoproteomics and cysteine proteomics
screens, lipid and carbohydrate analyses, metabolomics profiling, stable isotope tracing and specific MRM or
PRM assays of drugs and other small molecule metabolites. The Mass Spectrometry Shared Resource performs
all the data analysis for the quantitative screens and has developed new tools for the merging of large datasets
across multiple, independent experiments. All of these services are highly technical and labor intensive. Without
the Mass Spectrometry Shared Resource, it would be extremely difficult for individual investigators to have
access to this type of instrumentation and analyses and these types of services, which are often critical to their
research programs. In the last funding period the Mass Spectrometry Shared Resource has purchased four new
mass spectrometers (a Lumos and QEHF in 2016, and an ID-X and Exploris 480 in 2020), updated all the LCs
to ultra-high pressure systems (UHPLC), upgraded the main computer server to a 64-Core, 128-thread system,
and added a variety of devices to aid in sample preparation (CryoMill). Over the past five years, the Mass
Spectrometry Shared Resource was utilized by 20 Cancer Center members (53% of members), accounting for
a majority of its use. This Resource contributed to 33 publications or preprints by Cancer Center members over
this time period. In summary, the Mass Spectrometry Shared Resource provides the users with state-of-the-art
instrumentation and advanced technical support to help accelerate cancer research at CSHL.

Public health relevance
MASS SPECTROMETRY– PROJECT NARRATIVE Not required per PAR-20-043